Bridging the Gap: Implementing A Powered Mobility Intervention into Early Childhood Settings for Young Children with Cerebral Palsy (GMFCS IV-V)

PROJECT SUMMARY/ABSTRACT
Powered mobility (PM) interventions offer young children with motor disabilities, such as cerebral palsy, Gross
Motor Function Classification System (GMFCS) Levels IV-V, the opportunity to independently explore their
environments, which enhances their development and participation. PM experiences in early childhood (12-36
months) are crucial, as this period represents a critical window for development in the areas of cognition, social
abilities, motor skills, and daily participation. Despite these proven benefits, PM remains underutilized in early
intervention settings due to barriers, such as therapist attitudes, service delivery models, and insufficient
training and resources. Further complicating matters, no standardized approaches exist for PM interventions,
leaving a critical gap in both research and clinical practice. Early Childhood settings are the ideal setting for
implementing PM, as it targets a pivotal developmental stage, allowing for timely access to mobility solutions
that can foster independence and participation in daily activities. This project aims to address these barriers
by partnering with Early Childhood settings to develop therapist training for PM interventions tailored
for children with cerebral palsy, GMFCS Levels IV-V. Using an implementation science and community-
engaged research approach, this mixed-methods proposal will focus on three specific aims: Aim 1 involves
identifying the needs and barriers faced by early intervention therapists in utilizing PM interventions
through surveys and focus groups; Aim 2 aims to co-design a comprehensive therapist training with a
Community Advisory Board, which will inform and refine the development of therapist training by reviewing
identified needs, evaluating an existing PM intervention’s components, and providing feedback to ensure the
training’s relevance; and Aim 3 consists of conducting feasibility trial of the therapist training and PM
intervention implementation, assessing the trainings knowledge transfer, confidence, self-efficacy, as well as
and the intervention's acceptability, appropriateness, feasibility, fidelity, and pertinent child performance
outcomes. My career development goals include enriching my knowledge in pediatric PM intervention design,
acquiring skills in implementation science and community-engaged research approaches, enhancing my
scientific leadership, and improving my scientific writing skills. My mentors and I have developed a structured
4-year plan encompassing didactics, experiential learning, mentored research, and measurable milestones,
aligning with my research aims and maximizing my potential as an independent investigator in pediatric PM
intervention research. This proposal is responsive to PA-24-184, which seeks to ‘explore or understand the
mechanism of action of an intervention’ and ‘increase the pool of clinical researchers who can conduct patient-
oriented studies, capitalizing on the discoveries of biomedical research and translating them to clinical
settings.’ My ultimate goal is to bridge the gap between PM evidence and clinical practice, expanding access to
essential developmental and motor interventions for children with cerebral palsy.

Public health relevance
PROJECT NARRATIVE Children under the age of three with cerebral palsy, Gross Motor Function Classification System Level IV-V, experience significant motor disabilities and are at heightened risk for secondary impairments in motor skills, cognitive development, social abilities, independence, and daily participation due to limited independent mobility and restricted opportunities to explore their environments. Despite the demonstrated benefits of powered mobility interventions, they remain underutilized in Early Childhood settings, partly due to inadequate therapist training. This project aims to bridge that gap by partnering with Early Childhood settings to develop a therapist training and conduct a feasibility trial for implementing powered mobility interventions with children and caregivers in a home-based setting, ultimately expanding access to these critical interventions and improving developmental outcomes for children with cerebral palsy.